EpiGNOME: Epigenetic Graphical Networks Of Methylation Effectors for COPD Progression

EpiGNOME: Epigenetic Graphical Networks Of Methylation Effectors for COPD Progression
ABSTRACT
Modern clinical and translational sciences rely on big data to identify drivers of disease progression and develop
predictors of disease outcomes. Chronic Obstructive Pulmonary Disease (COPD) is a leading cause of death
and likely represents several molecular subtypes, which makes the prognosis and treatment challenging. Genetic
variation only explains a fraction of COPD pathogenesis. DNA methylation variability is particularly important
since it is more stable than gene expression and captures genetic influences and longitudinal exposures. Despite
its likely prominent role in disease and potential for therapeutic targeting, limited investigation has focused on
methylation, partly because of the analytic challenges posed by the high-dimensional and collinear data. This
project focuses on the investigation of the role of DNA methylation in COPD progression. We will develop novel
directed (causal) graph methods for high dimensional collinear data. These methods will provide a foundation
for advancing integrative computational systems biology by overcoming challenges inherent in large scale
methylation datasets. Through these new methods, applied at a population scale, we will identify potential cause-
effect relationships among DNA methylation and genetic and clinical effectors related to COPD subtypes and
progression. Our premise is that DNA methylation will reveal molecular mechanisms and drive the development
of stable COPD disease subtypes, not previously revealed with genetic and gene expression analyses. NHLBI's
Trans-Omics for Precision MEDicine (TOPMED) initiative includes a massive multi-Omic profiling program that
promises to break down barriers to understanding lung diseases. We will assemble results of genome-wide DNA
methylation analysis from leukocytes (two cohorts: COPDGene, LTRC), and lung tissue biopsies (two cohorts:
LTRC, LTCOPD); and longitudinal DNA methylation data from over 11,000 samples. These resources provide
the foundation for the development of a novel computational framework for DNA methylation analysis and will
enable us to further investigate COPD subtypes and identify effectors of COPD progression. The logic of our
approach begins with the identification of methylation marks directly linked to COPD outcomes from cross-
sectional leukocyte DNA methylation (Aim 1) and proceeds with similar analyses using repeated measures of
DNA methylation and pulmonary phenotypes (Aim 2). Finally, in Aim 3 we will identify COPD progression
subtypes and compare lung to blood epigenetic pathways. This project will advance algorithmic development
beyond standard methods; it will lead to generalizable insights into features of the epigenome that may drive
lung function decline and COPD progression; and identify stable COPD subtypes that will reveal new molecular
mechanisms and can be used to design new disease prevention and management strategies. This proposal is
a response to NOSI (NOT-HL-23-067), “Integrative Omics Analysis of NHLBI TOPMed Data”, with the bulk of
discovery and methods innovation leveraging extant TOPMed data.

Public health relevance
COPD is a leading cause of death, with heterogeneous manifestations influenced by epigenetic (DNA methylation) and genetic variation. New methods are needed for modeling the high- dimensional DNA methylation data, cross-sectionally and longitudinally, to identify factors causally linked to COPD progression. Identification of such features can help distinguishing COPD molecular subtypes, thus having translational relevance for prognostic and therapeutic interventions, which can be based on methylome targeting.